A Novel Small Molecule for the Prevention and Treatment of Diabetic Retinopathy

SUMMARY
Diabetic retinopathy (DR) is a leading cause of blindness in the United States. Currently, most treatments for DR
are only applicable at the late stage and are invasive. Anti-VEGF (vascular endothelial growth factor) agents
have achieved impressive therapeutic effects against DR and neovascularization (NV). However, 40% of patients
with DR have inadequate responses to the treatment. Given that DR is a multi-factorial disease, therapies that
target one single pathogenic factor (such as VEGF) are clearly insufficient to achieve desired efficacy in all DR
patients. Therefore, the development of novel, non-invasive, long-term and more effective pharmacological
treatments for DR is urgently required, particularly at an early stage of the disease. The overall objective of this
Phase II project is to develop a novel drug for the oral pharmacotherapy of DR. Peroxisome proliferator-activated
receptor α (PPARα) is a ligand-activated nuclear receptor that regulates mitochondrial lipid β oxidation and
peroxisome scavenge hydrogen peroxide in the cytoplasm. Two large and longitudinal clinical studies reported
independently that oral administration of PPARα agonist fenofibrate has robust therapeutic effect on DR in type
2 diabetic patients. This is the first oral drug with proven effect in DR patients. In preclinical studies with animal
models of DR, pharmacological activation of PPARα has been shown to decrease retinal pathologies typically
observed in DR (e.g. pathogenic neovascularization, vascular leakage and inflammation in the retina), resulting
in a profound therapeutic effect. Thus, PPARα represents a novel therapeutic target for the treatment of DR.
However, there are currently no FDA-approved PPARα drugs for DR. Our medicinal chemistry team has
synthesized and identified a non-fibrate, quinoline-derived small molecule A190, a novel PPARα agonist with
more potent activity. In SBIR Phase I studies, we have completed Proof-of-Principle studies demonstrating that
systemic administration of A190 is more effective than fenofibrate on two diabetic animal models. These studies
established A190 as a promising drug candidate for further development. The proposed research in Phase II will
focus on evaluating in vivo safety and toxicology of A190 in two species (rats and rabbits). In addition, the long-
term efficacy of orally administered A190 will be tested in DR models. This Phase II program includes three
specific Aims. Specific Aim 1: Evaluate and optimize the efficacy of A190 on retinal vascular leakage in DR
models. Specific Aim 2: Determine the pharmacokinetics of A190 and its ocular tissue distribution. Specific Aim
3: Assess possible ocular and systemic toxicities of A190. These studies will provide essential information for
IND-enabling studies and future clinical trials of A190 as an oral drug for DR.

Public health relevance
PROJECT NARRATIVE Diabetic retinopathy (DR) is a common complication of diabetes mellitus, affecting millions of patients in the US and worldwide. Clinical and experimental studies have established PPARα as a promising drug target for DR. Therefore, we propose to develop an orally bioavailable drug for DR, and our novel PPARα agonist A190 has great potential to become an effective oral drug for the treatment of DR.